Redirected CaMKII for restoring deficits in Alzheimer's disease models

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease is a progressive, degenerative brain disease. The major symptoms are impairments in
memory and cognitive functions. These changes accompany a significant loss of dendritic spines and, eventually,
neurons themselves. A defining pathological feature of Alzheimer's disease is the presence of amyloid plaques
and neurofibrillary tangles in the brain. There has been remarkable progress in understanding the
pathophysiological processes leading to this cellular pathology. Despite this progress, little is known about
molecular interventions to restore dendritic and memory deficits in Alzheimer's disease models. Converging lines
of evidence have documented a significant alteration in the subcellular distribution of calcium/calmodulin-
dependent protein kinase II alpha (CaMKIIa), which is a critical memory molecule, in many Alzheimer's disease
models. Evidence also indicates a close link between CaMKIIa dysregulation and tau pathology (phosphorylation
and inclusion) in various Alzheimer's disease models, highlighting CaMKIIa as a significant target molecule to
be intervened to restore the deficits seen in Alzheimer's disease. As such, approaches capable of redirecting
this dysregulation of CaMKIIa may offer unique avenues for the treatment of Alzheimer's disease. In this
application, we propose to explore this possibility. Our recent work reported a novel intrabody that specifically
targets N-methyl-D-aspartate receptors (NMDARs) located at the core of dendritic spines. We found that adeno-
associated virus (AAV)-mediated delivery of CaMKIIa conjugated with the anti-NMDAR intrabody results in
postsynapse-targeted local enrichment of exogenous CaMKIIa in the mouse hippocampus and a significant
increase in contextual fear memory of mice. Therefore, based on the complex formation and dynamics of
CaMKIIa, we propose to evaluate our molecular intervention in reversing the CaMKIIa dysregulation, tau
phosphorylation, dendritic spinopathy, and memory deficits in in vitro and in vivo models of Alzheimer's disease.
Knowledge of the functional roles of CaMKIIa dysregulation in Alzheimer's disease and subsequent tau
abnormality will clarify the pathways of Alzheimer's disease pathogenesis and has the potential to accelerate
progress toward Alzheimer's disease treatments by challenging the key memory pathway with a new but
validated molecular approach based on a solid foundation of knowledge in synapse biology.

Public health relevance
PROJECT NARRATIVE The proposed research aims to understand how redirected CaMKIIa improves neuronal dysfunctions and memory deficits in Alzheimer's disease models. Thus, this proposal is relevant to the part of the NIH's mission that pertains to understanding the mechanisms of Alzheimer's disease and related dementia and developing approaches for therapeutic interventions.